Driving Biomedical Projects - Functional genomics resources for the Drosophila

PROJECT SUMMARY – DRIVING BIOMEDICAL PROJECTS
We have identified a diverse set of driving biomedical projects (DBPs) that will serve as test-beds for
development of technologies by the Drosophila Research Screening Center-Biomedical Technology Research
Resource (DRSC-BTRR). The topic areas include cancer therapeutics, rare genetic disease, mosquito-borne
infectious diseases, and fundamental studies, for example in the areas of cell and developmental biology. We
will work with these researchers to ensure that technologies are tested by collaborators, further developed and
refined by the DRSC-BTRR, and applied to fit their research needs. We will also ensure that data generated by
and for one project are used to improve all relevant projects, for example as will be relevant in the area of
CRISPR pooled screens in Drosophila and mosquito cells, and in development of nanobodies for mosquito and
Drosophila targets. Altogether, our DBPs are well-positioned to test and benefit from the technologies, resulting
in studies with strong potential to provide new insights into a variety of fundamental and translational topics.